AAV-delivery of broadly neutralizing antibodies to augment ART-free control of HIV-1 in children

AAV-Delivery of Broadly Neutralizing Antibodies to Augment ART-Free Post-Treatment Control
of HIV-1 in Children
Initiation of antiretroviral therapy (ART) to infants with HIV-1 within 3 months of birth can durably
suppress HIV-1 replication, preserve immune function, limit the establishment and persistence
of viral reservoirs, and reduce HIV-related morbidity and mortality. However, rates of viral
suppression in early childhood are low due to the many challenges inherent in delivering
lifetime, daily ART. There is thus a critical need for new therapeutic approaches to achieve
durable HIV-1 control off ART in young children. This clinical trial planning grant, submitted in
response to PAR-23-206, addresses key barriers to the efficient translation of promising pre-
clinical data from infant macaque studies into a proof-of-concept POC Phase I clinical trial that
will evaluate whether a single administration of two AAV9-vectored broadly-neutralizing
antibodies (AAV9-VRC07-523LS; AAV9-10-1074LS) to children on ART will be safe, tolerable,
and lead to sustained production of bNAbs at levels that will allow control of HIV-1 replication
after ART discontinuation. Intramuscular AAV9 administration will selectively target long-lived
muscle cells using a dose likely to provide sustained in vivo production of antibodies with
minimal off-target effects and immunogenicity. Administration to young children capitalizes on
the relative tolerogenic immune milieu in early life to circumvent ADA, a major barrier to this
approach in adults. Primary trial outcomes include safety, pharmacokinetics (bNAb levels), and
the proportion of children who maintain HIV control (plasma HIV-1 RNA < LOD) off ART. To
enable efficient POC clinical trial development and implementation, we will coordinate multiple
partners to: 1) develop a full regulatory strategy; 2) complete a full clinical trial protocol and
associated documents; and 3) engage communities and ethics committees to inform clinical trial
development and implementation. Enabling the timely design and completion of the POC trial
will be an important step to advancing broadly accessible, safe, durable, and effective therapies
to achieve control of HIV-1 replication off ART in children.

Public health relevance
Work will advance development of a proof-of-concept Phase I clinical trial that will evaluate whether giving adeno-associated virus (AAV)-vectored broadly neutralizing antibodies (bNAb) to children with suppressed HIV-1 after early antiretroviral treatment (ART) will provide in vivo production of bNAbs at levels that will sustain control of HIV-1 replication off ART. Enabling long- term control of HIV replication off ART through this practical and scalable intervention would transform clinical care for children living with HIV.